CD4+ T-cell Repertoires of the Lung in Rheumatoid Arthritis

PROJECT SUMMARY
Rheumatoid arthritis (RA) is an inflammatory arthritis of autoimmune origin leading to erosive joint damage. While
B-cell involvement in RA is well characterized by antibodies to citrullinated protein antigens (ACPAs), much less
is known about T-cell reactivity and functionality in the etiology and pathogenesis of RA. Studies have focused
largely on the T-cells of the joint and peripheral blood. However, the joint is reflective of long-standing
autoimmunity which introduces a bias in adaptive immune responses due to epitope spreading. ACPAs exist
systemically and in mucosal sites preceding the onset of joint inflammation, which suggests the originating site
of autoimmunity in RA is extra-articular. The lung is one of these sites considered to be a possible location for
initiating RA-related autoimmunity. Notably, sputum ACPAs are detectable in over 33% of those at risk for RA
and over 66% of those with RA. Furthermore, lung abnormalities are seen in over 70% of those with RA, and
lung disease is a common extra-articular manifestation of RA. The goal of this proposal is to characterize the T-
cell repertoire of the lung in RA to better understand disease pathogenesis. This involves investigating both
phenotype and functionality of RA-related lung T-cells through single cell RNA-seq as well as the antigenic
reactivity of these T-cells through IL-2 bioassays when presented with synovial fluid antigens. Studying the T-
cell responses of the lung has been a challenge due to sampling limitations. Induced sputum is an inexpensive,
non-invasive sample but it typically contains 1% or fewer lymphocytes. We have overcome the limitations of
sputum for studying T-cell responses of the lung by the use of a novel microfluidic technique to recover sputum
lymphocytes in a completely touch-free and unbiased manner. This allows us to study the T-cells of the lung in
RA and compare them to the RA synovium as we hypothesize there will be shared effector states and antigenic
reactivity between lung-derived and synovium-derived CD4+ T-cells in RA. Our overall hypothesis is T-cells
derived from the lung have common effector states and antigenic reactivity to the T-cell repertoire of the RA
synovium. We will assess sputum lymphocytes in RA for the presence of Vβ17+ peripheral helper T (Tph) and
Vβ14+ cytotoxic CD4+ T-cells and compare T-cell receptor motifs and antigenic reactivity of T-cells in RA sputum
to RA synovium. From the single-cell RNA-seq data, we will also obtain TCR sequences of the RA sputum CD4+
T-cells. We will use previously published datasets containing TCR α and β chain sequences to determine closely
related TCRs and motifs between the RA synovium and lung. The findings from our proposal will allow for an
improved understanding of T-cell involvement in RA in both the lung as well as the joint.

Public health relevance
PROJECT NARRATIVE Rheumatoid arthritis (RA) is an autoimmune disease of unknown etiology that leads to erosive joint damage. While CD4+ T-cells are known to be important for RA pathogenesis, their exact role has remained unclear. Furthermore, lung involvement in highly prominent in those at-risk for RA and those with RA; yet, the T-cells of the lung have yet to be examined in the context of RA-related pathogenesis. The goal of this proposal is to characterize the CD4+ T-cell repertoire of the lung through gene expression determined by RNA-seq and reactivity to synovial fluid antigens to better understand CD4+ T-cell involvement in RA.